Bisphenol-Induced Blood-Brain Barrier Dysfunction in Alzheimer’s Disease

Identifying environmental risk factors for Alzheimer’s Disease (AD) is critical to mitigate cognitive decline in
humans. We provide first evidence showing that endocrine disrupting bisphenols (BP) are clinically relevant
environmental risk factors for AD. Human exposure to BPA and the bisphenol analogs BPF and BPS is inevitable
due to their ubiquitous presence in the environment. Our data show that BPA triggers blood-brain barrier
dysfunction and cognitive impairment, both hallmarks of AD, indicating that environmental BPs are a critical yet
underrecognized AD risk factor. Key characteristics of BP-induced barrier dysfunction include: 1) loss of the
amyloid-beta (Ab) clearance transporter P-glycoprotein (P-gp) and 2) development of barrier leakage. Both these
factors contribute to a pathological cascade that leads to cognitive decline in AD. While there is evidence that
BP exposure results in a dysfunctional barrier, the mechanism underlying this phenomenon is unknown, and key
mechanistic data linking BPs and AD are not available, which hinders our understanding of environmental risk
factors for AD. In this application, we address this critical unmet need and propose to define the relevance of
BPs as risk factors for AD. Our objective in this proposal is to define signaling steps through which BPs induce
barrier dysfunction and contribute to cognitive decline in AD. Based on preliminary data, our central hypothesis
is that BPs induce barrier dysfunction, increase Ab levels, and enhance cognitive decline in an AD model. Our
rationale for this research is that identifying the mechanism through which BPs induce barrier dysfunction and
exacerbate cognitive impairment will provide proof-of-concept that endocrine disruptors are an environmental
risk factor for AD. The hypothesis will be tested by pursuing three specific aims: 1) Identify the mechanism
responsible for BP-induced barrier dysfunction. 2) Determine BP levels, barrier dysfunction, and cognition in AD
patients compared to CNI. 3) Develop a strategy to repair BP-induced barrier dysfunction and slow cognitive
decline in vivo. In Aim 1, we will identify signaling steps that lead to BP-induced P-gp loss and barrier leakage in
isolated mouse brain capillaries, and we will verify these findings in capillaries from KO mice and in isolated
human brain capillaries. In Aim 2, we will determine BP levels and the degree of barrier dysfunction BP levels in
human tissue samples from cognitive normal individuals, preclinical AD, MCI and AD patients. In Aim 3, we will
block BP signaling to mitigate barrier dysfunction and evaluate the benefit of this strategy on slowing cognitive
decline in vivo in a mouse AD model. The proposed research is innovative because it represents a substantive
departure from the status quo by shifting to a mechanism-driven approach focused on the impact endocrine
disruptors have on barrier function and cognition in AD. The proposed research is significant because it is
expected to create a paradigm shift in our understanding of the importance of environmental risk factors for AD.

Public health relevance
The proposed research is relevant to public health because it is expected to identify bisphenols as environmental risk factors for blood-brain barrier dysfunction and provide a mechanistic link between bisphenols, barrier dysfunction, and cognition in Alzheimer’s disease. Thus, the proposed research is relevant to the missions of the NINDS, the NIA, and the NIEHS that pertain to developing fundamental knowledge of environmental impacts on human health that will help promote healthier lives and reduce the burden of diseases and conditions related to aging.